Epstein-Barr virus LMP1 mediated oncogenicity

Abstract
Epstein-Barr virus (EBV) is highly associated with multiple types of lymphomas, which occur
at elevated frequencies in people living with HIV. These include Hodgkin, Burkitt, post-
transplant, plasmablastic, primary central nervous system and diffuse large B-cell lymphomas,
which cause a large burden of disease in the HIV+ population. Despite highly active
antiretroviral therapy, HIV+ individuals have elevated risk for EBV+ malignancies, in particular
Hodgkin lymphoma. In people living with HIV, nearly all Hodgkin lymphoma and over 40% of
immunoblastic lymphomas are EBV+. The EBV oncogene Latent Membrane Protein 1 (LMP1)
is highly expressed in many HIV-associated lymphomas, including Hodgkin lymphoma. Yet,
much remains to be learned about critical LMP1 roles in lymphomagenesis, in particular with
HIV co-infection. Relatedly, much has remained unknown about specific LMP1 roles in germinal
center B-cells, a key B-cell state from which most EBV+ lymphomas arise, and how HIV co-
infection alters LMP1-dependent lymphomagenesis. Our preliminary data highlights that two
LMP1 C-terminal tail domains are non-redundantly important for primary human B-cell
transformation at distinct early timepoints post-infection, that each blocks distinct programmed
cell death pathways, that they synergistically induces PD-L1 checkpoint signaling, and that
germinal center cytokines are important determinants of LMP1 expression level. We have also
constructed recombinant EBV with point mutants that abrogate signaling by either or both LMP1
transformation essential (TES) regions and developed a novel model of EBV/HIV co-infection of
a novel secondary lymphoid microenvironment. Our aims test the central hypothesis that HIV
co-infection dysregulates germinal center B-cell LMP1 expression and signaling, resulting in
altered EBV+ B-cell reservoirs, checkpoint signaling and contributing to the observed elevated
rates of EBV+ lymphomas. In Aim 1, we will define key LMP1 TES1 and TES2 signaling roles in
B-cell oncogenic transformation and their relationship with HIV co-infection. In Aim 2, we will
identify how the secondary lymphoid microenvironment and HIV coinfection alter LMP1
expression and oncogenic effects on LMP1 target gene expression. In Aim 3, we will identify
how HIV/EBV co-infection alter checkpoint signaling, B-cell development and activation, and
responses to checkpoint blockade. Collectively, these studies will newly characterize key
aspects of LMP1 signaling in oncogenic B-cell transformation, including with HIV co-infection,
and will lay the foundation for novel therapeutic approaches.

Public health relevance
Public Health Relevance Statement Epstein-Barr virus (EBV) is a leading cause of cancer in HIV-infected individuals including Hodgkin lymphoma. These studies seek to identify how the key EBV-encoded oncogene LMP1 causes cancerous B-cell growth and how HIV co-infection potentiates this. These studies will increase understanding of how EBV and HIV subvert lymphocyte pathways present in specialized immune system nodes to contribute to lymphomas and may suggest novel therapeutic approaches.